Synthetic multi-component influenza vaccines to elicit broad immunity

PROJECT SUMMARY
Seasonal influenza viruses cause significant disease burden. While seasonal influenza vaccines are available,
these are often poorly efficacious due to mismatch with circulating virus strains, particularly in the populations at
greatest risk of complications from infection, including the elderly, infant, and immunocompromised. Influenza A
viruses (IAV) also pose a pandemic risk for which seasonal influenza vaccines provide no cross protection. In
2018, the National Institute of Allergy and Infectious Diseases (NIAID) released a strategic plan for developing
a universal influenza vaccine and subsequently released the FOA PA-18-859, “Advancing Research Needed to
Develop a Universal Influenza Vaccine.” The long-term goal of this proposal is to develop a universal influenza
vaccine.
We hypothesize that a flu vaccine composed of broadly cross-reactive B-and T-epitopes covalently linked to an
immune adjuvant will elicit potent immune responses and protect against diverse influenza A virus infections and
associated disease. This expectation is supported by our prior studies which demonstrated a fully multi-
component vaccine composed of tumor associated glycopeptide B- and CTL-epitope, a peptide CD4 T cell
epitope and a TLR2 agonist (Pam3CysSK4) elicited robust immune responses and protected against a stringent
tumor challenge in a murine cancer model. We will chemically synthesize multi-component vaccines that are
composed of conserved peptide antigens derived from IAV and an adjuvant such as Pam3CysSK4 or
monophosphoryl lipid A (Aim 1). In addition, we will employ an enzymatic glycan remodeling strategy to modify
recombinant hemagglutinin (rHA), which is used as a licensed flu vaccine, with various TLR agonists and DC
targeting moieties (Aim 2). It is expected that the self-adjuvanting rHA vaccines will enhance antigenicity of
conserved but poorly immunogenic stalk domain thereby providing heterologous protection. We will also explore
whether covalent attachment of immune-potentiators to recombinant neuramidase (rHA) can enhance its
immunogenicity and provide broad protection (Aim 3). The immunogenicity and efficacy of the vaccine
candidates will be evaluated in murine and ferret vaccination and challenge models, using innovative approaches
and antigen probes to assess polyfunctional T cell responses and geminal center (GC) B cell response. This
research is significant as it directly addresses multiple NIAID priorities in their strategic plan for developing a
universal influenza vaccine. The results of these studies could have a significant impact as the universal influenza
vaccines developed should be suitable for advancement to pre-clinical studies. Moreover, the adjuvants and
approaches developed in this proposal will be applicable to other vaccines and study of the host response to
influenza infection, and will have broader impacts beyond universal influenza vaccine development.

Public health relevance
PROJECT NARRATIVE Licensed flu vaccines suffer from loss of protection due to antigenic drift, lack of cross protection of zoonotic viruses, and poor immune responses in populations at greatest risk of complications from infection. We propose to develop a next generation flu vaccine that will provide broad and durable protection by chemically synthesizing compounds composed of cross-reactive T- and B-epitopes and an in-built immuno adjuvant. This research directly addresses goals in the NIAID strategic plan for developing a universal influenza vaccine and will provide candidate universal influenza vaccines as well as novel vaccine designs and adjuvants for other vaccine applications.